Resource Subawards Core

PROJECT SUMMARY RESOURCE CORE
Neurotech Harbor’s (NTH) Resource Core (RC) will accelerate and improve the chance of success of funded subprojects by working with all the other Cores in identifying, soliciting, evaluating, and managing Resources to produce a human-grade prototype. We will implement a 6-step process for each subproject that will move forward to NIH: (i) The Deep-Dive panel in the Evaluation Core (EC) will identify required resources and provide a list to the RC. (ii) The RC will identify a list of targeted providers within the Resource Network and give this list to the Outreach Core (OC). (iii) The OC will generate solicitations for each required resource and send these to the targeted providers, nationwide providers, and other BP hubs to share with their resource networks. The solicitations will encourage minority-owned and/or employed businesses to apply. (iv) Providers will submit their bids to the EC, who will select the most appropriate resource providers for the proposal package. (v)The proposal package, which includes the subproject proposal and proposal for the resource subaward, will be sent to the NIH by the Administrative Core. (vi) Funded Subprojects will be managed by the Innovator Core (IC) and the contracted resources will be managed by the RC.
The Proposal Package submitted to NIH will identify the Resources and funding needed in conjunction with the Innovators’ projects. Once funded, the RC will be responsible for managing the performance and deliverables for the Resources. Using the milestones, deliverables, and timelines identified in the Proposal Package and industry-standard project management tools, the RC will create a formal plan to manage and document the progress of each subaward and ensure success.
For this process to be successful, and to match all subprojects with the resources that they require, the RC must continue to grow its Resource Network and ensure proper management of the engagements between contracted providers and subproject teams. The RC will accomplish this through the following aims: (Aim 1) To manage Resource Subawards and ensure successful delivery of resources and services to Innovator subproject teams. (Aim 2) To develop and expand the Resource Network such that providers with services and facilities can be readily targeted for required subprojects. (Aim 3) To expand the Resource Network such that small-business providers are encouraged to participate.
To ensure that solicitations for services will be answered in a timely manner consistent with the accelerated review cycle expected from BP Hubs, the RC will have prequalified Resource providers, and created the support documents allowing evaluation of resource subaward proposals by the EC. These documents will help providers turn our solicitations around quickly. Finally, we will work with our (OC) partners to small business resource providers and encourage them to participate.